Novel Combination Therapies to Combat Hypermutable Carbapenem-Resistant P. aeruginosa

ABSTRACT: Carbapenem-resistant Pseudomonas aeruginosa (CRPA) poses an urgent threat to human health
in the United States and globally. Metallo-β-lactamases (MBL), which confer high-level carbapenem resistance,
warrant significant attention. The paucity of treatment options for CRPA MBL-producing Pseudomonas
aeruginosa (MBL PA) and the broken antibiotic pipeline demands the development of new therapeutic strategies
that target non-traditional, unexploited pathways. There is mounting evidence that ‘hypermutator’ strains, which
show a significantly increased spontaneous mutation frequency (10-fold higher than non-mutator control), serve
as the basis for pathoadaptation and antimicrobial tolerance, inevitably increasing the likelihood of treatment
failure and bacterial persistence in PA infections. Importantly, errors made during DNA replication and
translesion DNA synthesis (TLS Pol IV) serve as the mechanistic basis for mutations in PA hypermutator strains.
We have pioneered the synthesis and testing of novel non-natural nucleotides as remarkably safe and effective
anti-cancer therapies, which is supported by our preliminary data. For the first time, we now propose to study
non-natural nucleotides by defining the underlying mechanism of hypermutators in pathoadaptation, persistence
and antimicrobial resistance and develop combination regimens to combat MBL PA. Our overarching goal is to
develop new combinatorial treatment strategies for MBL PA using novel anti-mutator non-natural nucleotides
together with available β-lactam antibiotics. One promising bridge therapy for MBL Gram-negatives is
ceftazidime-avibactam combined with aztreonam; however, this strategy has not been studied in MBL PA. In
preliminary studies, we observed long filamentous persisters due to inhibition of penicillin binding protein 3 in
MBL PA exposed to the ceftazidime-avibactam and aztreonam combination. Since the SOS response to DNA
damage is required for filamentation, while TLS DNA polymerases (Pols) are required to bypass DNA lesions
generated in persister cell DNA leading to antimicrobial resistance, we hypothesize that in the absence of repair
functions, the ability of persisters to cope with DNA damage and subsequently septate and grow becomes
increasingly dependent on TLS Pol IV. Given this critically important role of PA Pol IV, our overarching
hypothesis that novel, non-natural nucleotides that target Pol IV to block replication of damaged DNA will be
highly effective together with existing β-lactam antibiotics. To test these hypotheses, we will: (Aim 1) define the
contributions of hypermutators to resistance and persistence of MBL PA exposed to β-lactam combinations;
(Aim 2) develop small molecule, non-natural nucleotides targeting TLS Pol IV to combat mutation in MBL PA;
(Aim 3) define optimal combinatorial treatment regimens of non-natural nucleosides and β-lactams that
suppresses resistance, and prevents persistence of MBL PA in hollow fiber and animal models. Taken together,
our results will provide unprecedented insight into novel combination therapies for Gram-negatives, and will set
the cornerstone for future testing of anti-mutator non-natural nucleotides in clinical trials.

Public health relevance
NARRATIVE Pseudomonas aeruginosa is an urgent, global, public health threat: highly resistant strains have emerged that possess a remarkable evolutionary capacity to adapt and persist in the face of therapy. In this project, our unifying focus is to develop novel combination therapies using novel non-natural nucleotides targeted at hypermutation together with existing antibiotic strategies involving β-lactam antibiotics. Taken together, our results will set the cornerstone for future testing of anti-mutators in clinical trials and provide unprecedented insight into combination therapies for Gram-negative urgent threats.